Targeting Endogenous Mesenchymal Stromal Cells with Ruxolitinib to Treat Sialadenitis in Sjogren's Syndrome

PROJECT SUMMARY
Sjӧgren’s disease (SjD), a common systemic autoimmune disease characterized by marked oral and ocular
sicca, has no disease modifying treatments available. Our long-term goal is to develop new effective therapies
for SjD. The objective of this application is to determine the mechanism through which ruxolitinib inhibits IFN-
induced pro-inflammatory salivary gland mesenchymal stromal cells (MSCs) and define the effects of ruxolitinib
on disease activity in SjD mouse models. The central hypothesis of the proposed studies is that IFN-
stimulated SG-MSCs, through STAT1 signaling, are pro-inflammatory and that ruxolitinib inhibits this pro-
inflammatory phenotype and ultimately reduces SG inflammation and restores saliva production in SjD mouse
models. The rationale for this hypothesis is based on our new data showing ruxolitinib abolishes IFN-induced
MSC activation and reduces MHCII upregulation in vitro through STAT1. These new data are pivotal because
they identify a possible mechanism by which the pro-inflammatory aspect of MSCs can be modified. The
central hypothesis will be tested by pursuing two specific aims: (1) Determine the effect of ruxolitinib on SG-
MSC immunobiology in vitro and (2) define the effects of ruxolitinib on SG-MSC and whole gland phenotype
and function in vivo. Under the first aim, SG-MSCs from SjD and control patients will be treated with IFN ±
ruxolitinib and phenotype and functional differences will be examined in vitro. Chromatin immunoprecipitation-
sequencing will be performed to determine the mechanism by which ruxolitinib imparts change in the
immunomodulatory profile of SG-MSCs. For the second aim, two SjD mouse models will be treated with
ruxolitinib or vehicle. SG-MSCs will be isolated and interrogated from each treatment group. Next, a global
salivary gland and systemic evaluation will be performed. The research proposed in this application is
innovative because traditionally the anti-inflammatory profile of IFN-treated MSCs has been the focus of
research. This proposal focuses on how IFN creates a pro-inflammatory MSC phenotype that can be inhibited
with ruxolitinib. Furthermore, SjD research has focused on JAK1 inhibition and we propose the use of a JAK1
& 2 inhibitor to treat SjD. The proposed research is significant because ruxolitinib holds promise as a feasible
modality to promote anti-inflammatory resident MSCs and for systemic SjD treatment. Should this pilot study
determine the mechanism by which ruxolitinib creates anti-inflammatory MSCs or that ruxolitinib improves SjD
in mice, these finding will be harnessed toward novel MSC-based or systemic treatment of SjD.

Public health relevance
NARRATIVE The proposed research tests new strategies to treat Sjӧgren’s disease (SjD), a common systemic autoimmune disease characterized by oral and ocular dryness and marked morbidity, with no available disease modifying treatments. Inhibiting JAK signaling to improve SjD glandular inflammation and to modulate salivary gland mesenchymal stromal cell’s (SG-MSC’s) immunoregulatory and regenerative capacity is critical to oral health and will impact human health by providing novel insights into the pathogenesis of SjD and serve as the first step toward two new potential and innovative therapies in SjD, 1) JAK1 & JAK2 inhibition to remodel SG-MSCs toward local MSC-based therapy, and 2) JAK1 & JAK2 inhibition for SjD treatment. Thus, the proposed research is relevant to the NIDCR’s mission that pertains to improving oral and dental health through research.